Validation and Improvement of ISPRI-HCP: An Innovative Platform for Immunogenicity Risk Assessment of Process-related Protein Impurities

ABSTRACT
The identification and removal of process-related protein impurities (PRPI) from biologic products is a critical
step in drug development. Despite recent improvements in the purification and processing of biologics, the
presence of immunogenic PRPI continue to raise concerns about drug safety and efficacy. We propose an
innovative approach for assessing immunogenicity risk of PRPI using our existing ISPRI-HCP platform. ISPRI-
HCP stands apart from conventional methods by utilizing a T cell approach based on the T cell epitope count
and density. We hypothesize that ISPRI-HCP can accurately classify candidate PRPI impurities according to
their immunogenicity risk. To test this hypothesis, we will determine the T cell immunogenicity of 8 frequently
found PRPI from Chinese Hamster Ovary (CHO) cell expression systems and 5 PRPI from adenoviral vaccines.
The selected PRPI classified by ISPRI-HCP cover a wide range of immunogenicity risk. Peptide pools comprised
of T cell epitopes of the selected proteins will be prepared and tested for their ability to induce antigen-specific
INF-g secreting T cells in assays using peripheral blood mononuclear cells (PBMCs). The overall goal of this
study is to provide proof-of-concept and further improve ISPRI-HCP as a platform for predicting the
immunogenicity risk of PRPI.

Public health relevance
NARRATIVE During drug development, products may contain protein impurities. These proteins may cause unwanted immune responses in the body and can change the safety and effectiveness of the drug. We developed an innovative program called ISPRI-HCP that predicts the likelihood a protein impurity will cause an unwanted immune response. In this study, we propose experiments to evaluate ISPRI-HCP and improve its ability to make predictions.